New Functions and Specificities of the Arg/N-Degron Pathway

Project Summary/Abstract
Regulated proteolysis by the ubiquitin-proteasome system (ubiquitin system) plays essential roles in
a multitude of biological processes and has major ramifications for human health and disease, including
illnesses that range from cancer and neurodegeneration to cardiovascular syndromes and defects of
immunity. Our studies of the ubiquitin-proteasome system and ubiquitin-dependent N-degron pathways
(previously called “N-end rule pathways”) over more than three decades were made possible, to a large
extent, by the present grant (GM031530), currently in its 37th year of support. N-degron pathways
recognize proteins containing N-terminal (Nt) degradation signals called N-degrons, polyubiquitylate these
proteins and thereby cause their degradation by the proteasome or autophagy. Recognition components of
N-degron pathways, called N-recognins, are E3 ubiquitin ligases that can target N-degrons. One eukaryotic
N-degron pathway, called the Arg/N-degron pathway, targets specific unacetylated Nt-residues of protein
substrates. This pathway, discovered by our laboratory in 1986, continues to be a fount of biological
insights. The Ac/N-degron pathway, discovered by our laboratory in 2010, recognizes proteins that bear
N-terminally acetylated residues. The other two proteolytic systems, the Pro/N-degron pathway and the
fMet/N-degron pathway, are mediated, respectively, by the E3s GID and Psh1, and recognize, respectively,
the Nt-proline (Pro) and the Nt-formyl-Met (fMet) residues of protein substrates.
This resubmitted GM031530 renewal application stems from our unpublished studies over the last
~2 years, contains results obtained the last ~10 months as well, and focuses on the mammalian
Arg/N-degron pathway, including the recently discovered ability of its E3s Ubr1/Ubr2 to bind to
transcriptional factors (TFs) Atf3, Fosl1, c-Fos, Fosl1, Prep1, and Prep2. Beginning with Atf3, we recently
showed that, in vivo, the binding of Atf3 to Ubr1/Ubr2 results in the degradation of Atf3 by the Arg/N-degron
pathway. These and other (related) studies, described in Specific Aims of the resubmitted GM031530
renewal application, will advance the understanding of protein degradation and the universally present (as
well as medically significant) Arg/N-degron pathway.

Public health relevance
Project Narrative Studies proposed in this renewal application for the GM031530-37 grant will address regulated protein degradation by the mammalian Arg/N-degron pathway, a proteolytic system universal among fungi, protists, animals and plants. Inborn or acquired defects in proteolytic systems are a major cause of many human diseases, including cancer, infections, cardiovascular illnesses and neurodegenerative syndromes. Our studies of the Arg/N-degron pathway, a specific ubiquitin-dependent proteolytic system, will contribute to advances in fundamental biology, and may lead to better therapies for specific medical problems.